VAREC Dissemination Core

Dissemination Core Abstract
The Vanderbilt AUD Research and Education Center (VAREC) Dissemination Core will utilize innovative
approaches to engage the public to destigmatize discussion of alcohol use disorder (AUD) and increase
understanding of the organ-based nature of this disorder. One approach will include a near-peer mentoring
program with area and rural high school students. The Core will also engage the AUD research community in
two respects. The core will organize summer research experiences in VAREC labs from undergraduates from
populations under-represented in STEM. The core will also provide virtual and in-person short courses to the
national AUD research community to increase facility with modern cutting-edge neuroscience tools to reduce
barriers to utilizing these technologies to advance alcohol research.